Unified Computation Tools for Natural Products research

Project Summary/Abstract
Accurate, reliable and efficiently obtained structure determinations and annotations are of increasing importance
in the current era of integrated omics research. Natural products continue to provide inspirational new structures
for drug discovery programs, and genomic studies of microorganisms, including our work with marine
cyanobacteria, have revealed that there are many times more secondary metabolites genetically encoded than
are typically expressed in cultures. Building on this knowledge, new methods in elicitation and heterologous
expression are successfully accessing this previously hidden genetic capacity for natural products biosynthesis.
Metabolomic profiling interfaced with improved molecule annotations has richly informed on regulatory
mechanisms of expression and the role of microbial interactions, especially including those involved in symbiotic
interactions. This continuing NIH supported program has developed several of the most widely used annotation
and analysis tools for MS and NMR natural product datasets, including GNPS, MASST, MassQL, SMART 2.1
NMR, DeepSAT, NP Classifier, NPOmix, SMART-Miner and PECAN, among others, and has led to 41 published
papers in the previous 4-year grant cycle. These publicly available tools have changed the way that diverse
scientists observe, organize, and make sense of complex metabolic profiling datasets from LC/MS and NMR
analyses. For example, over the last 12 months, the GNPS ecosystem of tools has been used by >50K users
from 156 countries and over the lifetime of the GNPS ecosystem, the community has analyzed over 25M LC/MS
samples. SMART 2.1 NMR and DeepSAT have been used by 2.3K users in 66 countries. Collectively, these
tools have democratized access to cutting edge computational approaches and are making an impactful
difference in the way that researchers probe small molecule-based interactions of diverse life forms. In this next
proposed grant period, we focus on machine learning and AI techniques to enhance the computational
approaches we have pioneered and expand the breadth of problems within small molecule analysis. Cottrell and
Gerwick will continue to develop annotation tools for even more precise predictions of structures and biological
properties from NMR data, including improved mixture analysis. New member Wang will innovate on the
integration of MS and NMR-based analyses to disambiguate closely related substances. Also, Wang will
continue to leverage extensive computational infrastructure to ensure public and online access to the tools
developed in this NIH program, democratizing their use and enhancing their impact. These overarching goals
lead to five specific aims that will provide the community of diverse chemists and biologists a set of easily
accessible tools for the improved identification of organic molecules and their properties by a variety of NMR and
MS based methodologies. These tools will be based on the most current methods available for machine learning
and artificial intelligence, thus successfully integrating computer science with analytical chemistry.

Public health relevance
Project Narrative Accurate, reliable and efficiently obtained structure determinations and annotations are of increasing importance in the current era of integrated omics research. This continuing NIH supported program has developed several of the most widely used annotation and analysis tools for MS and NMR natural product datasets; collectively these tools have democratized access to cutting edge computational approaches and are making an impactful difference in the way that researchers probe small molecule-based interactions of diverse life forms. In this next proposed grant period, we focus on machine learning and AI techniques to enhance the computational approaches we have pioneered, expand the breadth of problems within small molecule analysis, and further expand access to the wider community to these tools.